Defining the mechanisms by which NuMA drives spindle mechanical robustness

Project Summary/Abstract
Errors in chromosome segregation lead to aneuploidy, a hallmark of cancer where daughter cells
have extra or missing chromosome copies. Spindle pole defects, such as multipolarity, are one cause
of aneuploidy, indicating that pole integrity is critical to segregation fidelity. Thus, understanding how
the spindle’s mechanical robustness emerges to build and maintain proper poles is crucial to
understanding how the spindle accurately functions, and how it fails in disease such as cancer.
The protein NuMA and the motor dynein drive pole focusing by clustering microtubule minus-ends.
Given this role in pole focusing, altering NuMA expression or function could lead to cancer by
increasing multipolarity and aneuploidy. Indeed, NuMA is overexpressed in certain cancer types and
NuMA overexpression correlates with increased multipolarity and aneuploidy. However, the molecular
mechanisms by which NuMA gives rise to spindle mechanics and pole integrity, and its role in cancer,
are far from clear. Based on recent work and preliminary data, I hypothesize that NuMA plays two
separate roles in spindle mechanics and that NuMA disruptions in cancer cells affect both roles: a
passive (non-energy consuming) role crosslinking microtubules and a role regulating the motility of
the active motor dynein. Either or both roles could be disrupted, and targeted, in a cancer context.
Here, I propose to test this hypothesis by combining molecular and mechanical perturbations,
microscopy, and quantitative image analysis in human metaphase cells. In Aim 1, I will test whether
and how NuMA plays a dynein-independent, passive role in spindle mechanics. To do so, I will use
PDMS-based cell confinement to mechanically challenge normal and cancer spindles where NuMA
can and cannot interact with dynein, and will compare how poles structurally fail under force. In Aim 2,
I will determine how NuMA regulates dynein function to drive spindle mechanics. Using a functional
NuMA/dynein transport assay, I will test whether and how NuMA regulates dynein force generation in
the spindle. Specifically, I will compare the ability of different NuMA mutants to change dynein force
generation, focusing on a mutant that lacks the coiled-coil suspected necessary for dynein activation
and a mutant preventing NuMA from oligomerizing and clustering dyneins together. Finally, I will use
these same NuMA mutants and cell confinement to test if NuMA regulating dynein is essential for
pole mechanical integrity in cancer spindles.
Together, these aims will determine how the essential protein NuMA drives spindle mechanics
and how NuMA’s active and passive roles contribute to its disrupted function in cancer cells. As such,
this work will allow us to identify mechanisms for spindle pole failures and may provide new
therapeutic strategies to control multipolarity and aneuploidy in cancer.

Public health relevance
Project Narrative When a cell divides, it must segregate the genome equally into two daughter cells, and segregation errors can lead to cancer. The spindle is the machine that segregates our chromosomes, and the protein NuMA is essential for building a spindle with two focused poles, and thereby for segregating chromosomes accurately into two groups. NuMA is misregulated in cancer, and here I propose to uncover how NuMA generates force to build the spindle, which in the long term may lead to new therapeutic avenues.